Harnessing the Cholinergic Inflammatory Reflex to Alter Neuroinflammation and Neuropsychiatric Consequences Following Traumatic Brain Injury

Worldwide, traumatic brain injury (TBI) contributes to more death and disability than other trauma-related
injuries. Recent statistics indicate that 69 million people are affected by this “silent epidemic,” with 4.6 million
affected persons residing in the United States and Canada. Military personnel are especially vulnerable to TBI,
considered a signature injury of recent wars. These closed-head, shockwave-induced blast TBIs (bTBI), caused
by proximity to explosive devices, lead to neuropsychiatric impairment that significantly affects the quality of
life after injury. Neuroinflammation is linked to neuropsychiatric illness in the general population and thus,
may mediate these impairments. There is a critical need for effective anti-inflammatory treatments for blast
TBI, an area of active investigation. Extensive research shows that select neuromodulatory and
pharmacotherapy tools can be used to activate the cholinergic inflammatory reflex to modulate
neuroinflammation, but it is unknown whether either approach can be used after bTBI. The current application
will address these gaps in knowledge by determining the utility of vagus nerve stimulation, a neuromodulation
tool, and anatabine, a full-cholinergic agonist, using a rodent model of bTBI. Vagus nerve stimulation (VNS),
an FDA-approved neuromodulation treatment for select neuropsychiatric disorders, is currently being explored
for various inflammatory conditions and neurorehabilitation. Anatabine is similarly being examined for
neurorehabilitation, but neither treatment has been used for blast-related, closed-head injuries. The current
study aims to address this knowledge gap by completing the following short-term goals in a pre-clinical
(mouse) model of bTBI: 1) understand whether the cholinergic pathway can be targeted to alter the
inflammatory response to bTBI, and 2) understand whether targeting this pathway can reduce
neuropsychiatric deficits that substantially affect the quality of life after injury. These goals will be achieved by
completing three specific aims: 1) Characterize the neuroinflammatory response to bTBI as it relates to the
neuropsychiatric consequences of injury, 2) Determine the effectiveness of VNS to alter the immune response
to improve neuropsychiatric consequences of bTBI, and 3) Determine the effectiveness of a cholinergic agonist
to alter the immune response to improve neuropsychiatric consequences of bTBI. Our preliminary data and
recent VISN1CDA support our hypotheses and the feasibility of carrying out the proposed research. The current
project is designed to extend our proof-of-principle work to clearly define the utility of these novel treatments.
If successful, this promising neuromodulation treatment could advance the standard of care for military
personnel and improve the quality of life for Veterans and their families. The current Career Development
Award-2 will be performed at the White River Junction VA Medical Center and incorporates existing
infrastructure and equipment, including a blast tube apparatus, unique equipment that recapitulates battlefield
injuries. The candidate has scientific experience with pre-clinical models evaluating dysfunction in the
autonomic nervous system and immune system. She has over ten years of research experience, including
animal models of disease and neurotrauma, microsurgery, neuromodulation, immunohistochemistry,
histology, and microscopy. Dr. Noller has assembled a mentoring team consisting of leading VA scientists and
physicians with extensive experience mentoring early career investigators towards independence. The scientific
team also includes local experts for consultation on specific aspects of the work. The immediate research
activities will support Dr. Noller’s long-term career goal of becoming a translational VA scientist. Specifically,
the CDA-2 will provide protected time while she receives mentored training in neuroinflammation,
neuroanatomy, quantitative neuropathology, and neurobehavioral assessment of rodents. Collectively
completing the research activities and mentored and specialized training will establish her expertise in the field
and culminate in full research independence as a VA Research Scientist.

Public health relevance
Relevance to Veterans’ health and healthcare: Shockwave-induced, blast traumatic brain injury (bTBI) is a significant problem for U.S. service members, including combat Veterans. The debilitating neuropsychiatric consequences associated with bTBI necessitate an effective intervention. The current application aims to meet this critical need by determining the utility of neuromodulation and pharmacotherapy to reduce neuroinflammation, which may mediate associated neuropsychiatric impairment. In a rodent model, we will test two treatments that target the same anti-inflammatory pathway, vagus nerve stimulation (VNS) and anatabine, with the ultimate goal of human translation. Both VNS and anatabine have shown efficacy in experimental testing but have yet to be used for bTBI. If successful, these treatments have the potential to improve the quality of life of service members and advance the standard of care for military personnel who have experienced bTBI.